Neural oscillations underlying speech perception and production in childhood stuttering

Project Summary/Abstract
There is a fundamental gap in our understanding of the temporal dynamics underlying the auditory-motor
integration deficits consistently observed in children and adults who stutter. Fluent speech requires coordinated
neuronal activity that is achieved through neural oscillatory synchrony across brain structures. This proposal will
focus on the oscillatory synchrony facilitating neural communication within the speech network. Our long-term
goal is to determine empirically-based neural markers for persistent stuttering, findings that may eventually
inform the clinical diagnosis and treatment of childhood stuttering. The overall objective of the present
application is to determine how children who stutter (CWS) differ from fluent peers in neural oscillatory synchrony
across auditory-motor structures during speech perception and planning. Guided by EEG and MRI data collected
from children who do and do not stutter, our central hypothesis is that beta oscillations, which control predictive
timing of movements through coordination of motor to auditory systems, will show aberrant power, reduced inter-
trial phase clustering, and reduced interregional oscillatory phase synchrony in CWS. A better understanding in
this area has exciting treatment implications, since manipulation of synchrony within oscillatory patterns in
auditory-motor systems may be possible through entrainment with external sensory stimuli and non-invasive
brain stimulation. This project will thus allow us to lay the groundwork towards systematic, neurobiology-based
intervention development for CWS. Guided by strong preliminary data, the central hypotheses will be tested by
pursuing three specific aims: 1. Identify and characterize beta power and oscillatory synchrony in auditory-
motor cortical areas during speech perception and planning in CWS. 2. Compare beta power and oscillatory
synchrony in auditory-motor cortical areas during natural and entrained (paced) speech planning in CWS. 3.
Determine how beta oscillation characteristics in auditory-motor areas relate to structural and functional
connectivity among auditory, motor and striatal regions in CWS. The proposed work is innovative, as it will be
the first series of studies designed to characterize neural oscillatory synchrony specific to speech processing in
CWS, which may serve as a highly predictive neural marker for persistent stuttering during early childhood.
Findings will be significant, because the expected results will elucidate, for the first time, causal mechanisms
behind auditory-motor integration deficits in persistent stuttering. Such results will have an important positive
impact, as the identified neural mechanisms underlying fluent speech will lay the foundation for effective early
intervention for stuttering.

Public health relevance
Project Narrative The proposed studies address an important and under-investigated area of childhood developmental stuttering pertaining to neural oscillatory synchrony underlying auditory-motor integration that supports speech perception and production. Using a multimodal imaging approach that combines both EEG and MRI data, the results of the proposed studies are expected to clarify for the first time the temporal dynamics of neural connectivity that are affected in children with persistent stuttering. These studies are expected to guide future intervention development that targets enhancing auditory-motor integration through manipulation of neural synchrony.